Early intervention with anti-proliferative therapy close to ART initiation to limit long-term SIV persistence

PROJECT 1 SUMMARY
HIV persists despite decades of antiretroviral therapy (ART) because of a population of latently infected CD4+
T cells known as the HIV reservoir. The HIV reservoir is sustained by proliferation of infected CD4+ T cells, which
do not express enough viral protein to be eliminated by HIV-specific immune responses. While proliferation of
cells is a promising target for curing HIV and eliminating the need for lifelong ART, a comprehensive preclinical
structure to develop a lymphocyte anti-proliferation therapeutic strategy does not exist.
Recent evidence suggests that CD4+ T cell proliferation plays a vital role in generating multiple proliferative
clones of latently infected cells extremely early during untreated HIV infection. We developed a mathematical
model which suggests that massive CD4+ T cell proliferation coincident with recovery from CD4+ lymphopenia,
occurs during weeks 1-4 of primary HIV infection and is vital for generating much of the HIV reservoir. We
hypothesize that effective anti-proliferative (AP) therapy given during this critical three-week window will limit the
volume and alter the clonal structure of the HIV reservoir.
In Aim 1 of this application, Dr. Adam Spivak will test small molecular agents targeting CD4+ T cell
proliferation given alone and in combination. A comprehensive library of immunomodulatory and
chemotherapeutic agents with high therapeutic potential will be tested for their AP effects ex vivo on CD4+ T cell
cultures, ex vivo on latently HIV-1 infected cells derived from human donors, and in vivo in uninfected rhesus
macaques by measuring impact on CD4+ T cell turnover using deuterium water labeling. Finally, Dr. Joshua
Schiffer will utilize mathematical models which capture drug pharmacokinetics and pharmacodynamics, as well
as the underlying dynamics of CD4+ T cell subsets within the HIV reservoir, to optimize selection of single drug
or combination anti-proliferative (AP) regimens for dosing of SIV infected animals in Aim 2.
In Aim 2, Dr. Joseph Mudd will evaluate the effects of optimized AP agents on early reservoir formation
dynamics in 24 SIV-infected rhesus macaques: 6 will receive ART alone between weeks 1-25 post infection; 6
will receive ART alone between weeks 4-28 post infection; 6 will receive ART between weeks 1-25 and optimized
AP therapy between weeks 1-4 post infection; 6 will receive ART between weeks 4-28 and optimized AP therapy
between weeks 1-4 post infection. Optimized AP regimens will be selected from Aim 1.
During ART, we will measure the in vivo AP therapeutic effect on 1) SIV reservoir volume with total and
intact SIV DNA, 2) reservoir CD4+ T cell subset composition, 3) in vivo CD4+ T cell turnover with D2O labeling,
and 4) SIV reservoir clonal structure using integration site sequencing, based on frequent longitudinal sampling
of blood and gut tissues. After 24 weeks of ART, we will stop ART and monitor viral rebound for up to 4 months.
We hypothesize that AP therapy between weeks 1 and 4 post infection will reduce total and intact SIV DNA and
decrease reservoir clonality following 6 months of ART, and increase time to SIV rebound after ART interruption.

Public health relevance
PROJECT NARRATIVE HIV requires lifelong antiviral treatment because it persists within a population of silently infected cells termed the HIV reservoir. If treatment is permanently stopped, HIV reemerges and escapes from the immune system leading to AIDS. In this proposal, we will test a strategy to limit formation of the HIV reservoir by targeting proliferation of silently infected cells during the first month of infection.